Reducing blood pressure in mid-life adult binge drinkers: the role of microvascular function and sympathetic activity

The candidate is committed to identifying/developing preventative and therapeutic approaches for alcohol-
induced hypertension and cardiovascular disease. This application will provide a 5-year career development
plan which has been tailored to optimize opportunities and to develop unique research skills that could not be
mirrored in any other environment. During the K99 phase, the candidate will obtain research training and
professional development in the field of alcohol research. The candidate will develop a unique research
strategy that integrates vascular physiology, physical therapies and alcohol-related human health. The
candidate will apply the strategy to address the gaps in knowledge of the mechanisms underlying elevated
systolic blood pressure (SBP) associated with binge drinking targeting mid-life adults (50-64 years). One fifth of
mid-life adults reported binge drinking and more than half reported having hypertension. However, this age
group has been understudied in alcohol research. In healthy young adults (18-30 years) with normal SBP, the
candidate has found that repeated binge drinking is associated with reduced microvascular function, measured
as flow-induced vasodilation (FIV) in small resistance arteries. The candidate has also found that repeated
binge drinking is associated with increased levels of urinary norepinephrine, a vasoconstrictor and a marker of
sympathetic nerve activity. In a later mid-life stage, the synergistic effect of repeated binge drinking and aging
may aggravate these adverse changes in FIV and sympathetic activity, causing elevated SBP. The proposed
study will determine the effect of repeated binge drinking on microvascular function, sympathetic activity, and
blood pressure in mid-life adults and the reversibility of these adverse changes. Aim 1 will determine the role
of norepinephrine as a potential moderator of reduced arteriolar FIV associated with repeated binge drinking.
FIV will be measured in resistance arteries, the major regulatory site of SBP, isolated from fat biopsies of mid-
life adult binge drinkers vs. alcohol abstainers/moderate drinkers. Aim 2 will determine sympathetic nerve
activity (directly via microneurography) and SBP (resting and ambulatory) in mid-life adult binge drinkers vs.
alcohol abstainers/moderate drinkers. The findings of this approach will potentially establish therapeutic targets
for alcohol-attributable contribution to elevated SBP and have broader implications for understanding
hypertension development in mid-life adults. The findings will also launch the R00 phase of independent
research where in Aim 3 the candidate will investigate the feasibility and effectiveness of high-intensity interval
training on improving FIV and reducing sympathetic activity, thereby reducing SBP in mid-life adult binge
drinkers. The clinical and mechanistic data will build the foundation for an R01 studying the mechanisms of
alcohol induced elevated SBP, and an intervention focusing on microvascular function and sympathetic activity.
The study has high impact for understanding the mechanisms of cardiovascular risk development in mid-life
adults and is highly responsive to the mission of the National Institute on Alcohol Abuse and Alcoholism.

Public health relevance
Project Narrative Repeated binge drinking is associated with elevated systolic blood pressure, which confronts more than half of mid-life adults in the United States. This K99/R00 application proposes training and research to develop a research strategy that integrates vascular physiology, physical therapies, and alcohol-related health. This will address the gaps in knowledge of mechanisms underlying alcohol-attributable contribution to elevated blood pressure and help identify/develop therapeutic approaches to decrease the burden of hypertension in mid-life adults.